Acquisition of a core research microscope for imaging long-term cellular signaling dynamics and optogenetic manipulation

Project Summary
This project is an administrative supplement request in response to NOT-GM-22-017. The objective of this
project is to expand the capabilities of the CRISPR-IMAGE research support core as part of parent award
(COBRE, 5P20GM135008) with a microscope to enable optogenetic manipulating and imaging of signaling
dynamics, molecular reorganization, and cellular movements on the time scale of inflammation and
resolution (hours to days). This instrumentation’s implementation capitalizes on new expertise brought into
the COBRE center with the hire of a new director for our CRIPSR-IMAGE core. This direction will expand
our institutional capacity for the analyses of cellular-to-tissue inflammatory process by direct visualization
and quantification of cellular dynamics during cellular and tissue-level processes such as differentiation,
immune polarization, and responses to oxidative stress. In addition to increasing our capacity for research
within the COBRE, this instrument will be used for graduate education via a hands-on course taught by the
director (with currently 18 students/year) and it will be available to users from across campus studying
diverse cellular processes ranging from bacterial to plant systems.

Public health relevance
Narrative The cellular processes of inflammation involve dynamic cellular changes that occur on timescales of hours to days. This instrumentation will expand biomedical research capacity and contribute to the understanding of how cellular dynamics shapes inflammation, leading to new understanding and development of novel therapeutic strategies.